Supporting FDA's Integrated Food Safety System Training Delivery and Development

Project Summary/Abstract
Dr. Thompson, as PD/ PI, Professor and Director of CAFSP and Co-Director of the TN COE, UTK is submitting
an application to continue support of FDA’s efforts to modernize the approach to training IFSS human and
animal food safety professionals and addressing capacity to design and develop content for new or existing
classroom and web courses, virtual events, reference resources, job aids, or other tools needed to design and
develop engaging regulatory curricula utilizing adult learning principles. She has assembled a strong team with
experience in food safety, instructional design, information technology, 508 compliance, and video
development. Requested funds will support OTED priorities and mutually agreed upon projects to address
these 2 focus areas: 1) Course Planning, and 2) Course Design, Development and Evaluation. UTK has the
following specific aims: 1) Support OTED’s course delivery needs and ensure that participants experience a
quality learning outcome; 2) Support course design, development and evaluation projects to meet OTED’s
needs and priorities using high quality, innovative and cost-effective approaches; 3) Implement a flexible
approach to establishing workplans and timelines to adjust for unanticipated circumstances based on changes
to OTED needs and priorities; 4)Explore innovative approaches to enhance participants’ overall learning
experience while also considering cost effectiveness and timeliness; and 5) Fulfill all necessary reporting and
meeting requirements to ensure lines of communication are open and that effective coordination occurs with
all FDA personnel to implement timely and high-quality outcomes. UTK will provide the following deliverables.
Under Focus Area 1 on Course Planning, UTK will continue its successful delivery of FD190 Food Current Good
Manufacturing Practice, Application, and Evidence Development and its related Train-the-Trainer and will
cover all aspects of a delivery including: 1) Recruiting IFSS SMEs and providing instructor skills training and
other OTED mandated training to SMEs identified as potential course instructors; 2) Ensuring instructors are
trained on how to deliver all course components including scheduling TTT sessions as needed; 3) Evaluating
instructor performance to assure course content is delivered in compliance with FDA/OTED instructional
standards; 4) Maintaining and submitting all necessary course records; 5) Developing annual work and project
plans in collaboration with OTED; and 6) Developing a course delivery schedule in concert with OTED's work
planning. Under Focus Area 2 on Course Design, Development and Evaluation, UTK will support OTED’s
identified priorities and will implement innovative and cost-effective approaches to: 1) Develop or revise course
design documents, storyboards, assessments, knowledge checks, graphics, videos, exercises, and instructor,
administrator, and participant manuals; 2) Establish project plans/ timelines in collaboration with OTED; 3)
Develop annual work and project plans; 4) Review and pilot classroom course content; and 5) Review and pilot
web-based course content (content/functionality testing/508 compliance testing).

Public health relevance
Project Narrative A well-trained Integrated Food Safety System (IFSS) workforce is essential to ensuring a safe and secure food supply in the United States. The proposed initiative addresses a critical gap in the training infrastructure for SLTT regulatory agencies by modernizing traditional training models that are no longer sufficient to meet the growing demand and creating innovative and cost-effective learning strategies for the IFSS workforce. The project deliverables will have the expected outcome of supporting FDA’s efforts to enhance IFSS human and animal food safety professionals’ competencies to ensure consistent and effective regulation and positively benefit food safety in the US.